TRYPTOPHAN AND TRIGLYCERIDES PLASMA LEVEL

Study effects of dietary MCT's and total fat on the plasma level of free and bound tryptophan and its correlation to plasma serotonin levels, and to evaluate the impact of a tryptophan-rich dietary supplement on these parameters.